Kallikrein-kinin system and regulation of lupus autoimmunity: pathways from periphery to brain

Project summary:
Neuropsychiatric Lupus (NPSLE) is a common but under-researched aspect of systemic lupus erythematosus
(SLE). Symptoms include anxiety, depression, and cognitive impairment. NPSLE severity varies, indicating a
complex pathogenesis. Excessive Type I interferon (IFN) production and response is a hallmark of SLE. High
IFNα levels correlate with depression and anxiety in lupus patients and mice. Targeting theType I IFN response
is a therapeutic goal. The FDA has approved anifrolumab, an anti-IFN receptor antibody, for moderate to severe
lupus; however, its efficacy in NPSLE remains untested. IFNAR blocking in pre-clinical models has shown varied
outcomes, suggesting complex IFN regulation in different lupus models and highlighting the need for alternative
IFN suppression pathways. Our research discovered that the kallikrein-kinin system (KKS) can suppress Type I
IFN response, introducing a new pathway for IFN suppression. KKS regulates many physiological processes,
including inflammation and brain functions. KKS components, including kallikreins and bradykinins, along with
ACE inhibitors (ACEi), suppress IFN responses in lupus models. Administering the ACEi captopril in lupus mice
reduced IFN gene expression, neuroinflammation, and depressive behavior. Exogenous kallikrein-1 (klk1) also
improved depressive behavior and reduced IFNα levels in lupus mice. NPSLE symptoms appear early in lupus,
indicating a role of peripheral autoimmunity. Brain-reactive antibodies, cytokines, and inflammation contribute to
NPSLE pathogenesis. Extracellular vesicles (EVs) from SLE patients carry inflammatory cargo and may
influence NPSLE. High levels of cell-free DNA (cf-DNA) is found in SLE patients and the importance of cf-DNA
as a biomarker and immune mediator is researched extensively. Reducing peripheral IFNα could reduce CNS
inflammation and improve symptoms. We hypothesize that excessive peripheral IFNα, production and response,
causes NPSLE. Reducing IFN responses with ACEi and klks will decrease CNS inflammation and behavioral
symptoms. In aim 1, we will dissect the cellular and molecular mechanisms by which the KKS and ACEi modulate
IFN pathways. Using DC and microglia as cell models, we will analyze these mechanisms in the periphery and
brain, respectively, in established NPSLE models (MRL/lpr and NZBW/F1), and in the new microglia specific
IFNAR-knockout B6/lpr model. We will correlate these molecular mechanisms with behavioral outcomes. In aim
2, we will analyze the pathways by which peripheral immune responses affect neuroinflammation and behavior
in the models in Aim 1. We will focus on the effects of circulating peripheral components (EVs and cf-DNA) from
mouse and human cells on brain cells (primary mouse cells or human cell-lines). We will also analyze parallels
in IFN-KKS related gene/protein profiles in EVs from lupus patients’ samples (SLE and NPSLE). These studies
aim to (1) elucidate the therapeutic potential of KKS molecules in SLE and NPSLE, (2) understand the
mechanisms of ACE inhibitors, (3) identify and validate novel peripheral biomarkers for NPSLE prognosis, and
(4) provide insights into peripheral-brain interactions in chronic inflammation.

Public health relevance
Project Narrative This R01 proposal aims to analyze pathways by which the kallikrein-kinin system (KKS) regulates lupus autoimmunity, with special focus on how peripheral immune responses affect the brain in neuropsychiatric lupus (NPSLE), in animal models and human cells. The effects of peripheral dendritic cells (DC) and cell-free components in blood on brain cells, and the disease outcome (systemic and neurolupus) after treatment with molecules in the KKS pathway will be analyzed. There is currently no specific treatment for NPSLE; results of this study will provide a rationale to use candidates from the KKS for systemic lupus and NPSLE treatment and identify peripheral biomarkers for NPSLE management.